PREP@UNM Competing Renewal

Project Summary/Abstract
The University of New Mexico Postbaccalaureate Research and Education Program (PREP @ UNM) is a
biomedical research training program, focused on individuals from minority and historically underrepresented
groups who intend to enter a Ph.D. program. Based on a series of defined objectives we will: recruit well-
qualified under-represented scholars to our program; create and realize individualized development plans to
provide laboratory research experience and tailored skills for academic, professional, and personal growth;
provide support for successful application of scholars to Ph.D. programs and careers in the biomedical
research workforce; and investigate the parameters impacting graduate school retention and utilize these data
to improve graduate training at UNM. We anticipate that this training will notably increase the number of well-
trained under-represented individuals in the sciences.

Public health relevance
Project Narrative This project's relevance to human health is through direct training of diverse individuals in biomedical science fields and their subsequent strong performance in Ph.D. programs. The scholars we train will enter the biomedical research workforce and contribute to understanding and ameliorating human disease.